New Inactivators of GABA Aminotransferase for Epilepsy and Neuropathic Pain

Project Summary/Abstract
The two principal neurotransmitters involved in the regulation of brain neuronal activity are -
aminobutyric acid (GABA), one of the most widely distributed inhibitory neurotransmitters, and L-glutamic acid,
an excitatory neurotransmitter. The concentration of GABA is regulated by two pyridoxal 5'-phosphate (PLP)-
dependent enzymes, L-glutamic acid decarboxylase (GAD), which catalyzes the conversion of L-glutamate to
GABA, and GABA aminotransferase (GABA-AT), which degrades GABA to succinic semialdehyde and
converts -ketoglutarate to L-glutamic acid. When the concentration of GABA diminishes below a threshold
level, convulsions result; raising GABA levels terminates the seizure. When epilepsy is defined broadly as any
disease characterized by recurring convulsive seizures, then over 1% of the entire world population (including
>3 million Americans) can be classified as having epilepsy. One approach to raise GABA levels is with a
molecule that crosses the blood-brain barrier (BBB) and inhibits/inactivates GABA-AT. This effectively
dampens excessive neural activity without affecting basal neuronal firing. Vigabatrin (Sabril®) is an FDA-
approved drug that inactivates GABA-AT and is used to treat infantile spasms and refractory epilepsies;
however, it has serious side effects. Neuropathic pain, including chemotherapy-induced peripheral neuropathy
(a problem for more than 60% of cancer patients treated with chemotherapy), affects 3-17% of the world
population. Inadequate current treatments of pain are exacerbated by adverse side effects, such as abuse
liability, sedation, and altered mental status, which limit treatment utility. Two features of neuropathic pain that
have been identified are reduced GABA levels and spinal GABAergic inhibitory function. The objective of this
proposal is to design and evaluate new mechanism-based inactivator analogs of our previously successful
GABA-AT inactivators to enhance potency and elucidate inactivation mechanisms using computer modeling
and crystallography (Dr. Dali Liu does our crystal structures) as the driving force for design. New inactivators
are being designed for selective GABA-AT inactivation. This will require the use of comparative computer
modeling with structures of compounds bound to several other aminotransferases. A new approach from our
group will be the design of two classes of analogs for improved BBB penetration: a passive diffusion approach
involving simple prodrugs of our previously successful GABA-AT inactivators; and an active diffusion approach
in which molecules known to bind to three different BBB influx transporters will be incorporated into our GABA-
AT inactivators as prodrugs. Finally, the effectiveness of our new molecules will be tested by my collaborator,
Dr. Andrea Hohmann, for their effect on various neuropathic pains, including chemotherapy-induced peripheral
neuropathy. They also will be sent to the NINDS Preclinical Screening Platform for Pain and to the NINDS
Epilepsy Therapy Screening Program to determine their effectiveness in various in vivo epilepsy models.

Public health relevance
Project Narrative When the concentration of -aminobutyric acid (GABA) diminishes in the brain, convulsions can occur and neuropathic pains can prevail. Inhibition of GABA aminotransferase raises GABA levels and can terminate convulsions and ease neuropathic pain. We propose to design, synthesize, study inactivation mechanisms, and evaluate in vitro and in vivo new compounds to inactivate GABA aminotransferase.